Graduate Training in Biostatistics

This is a request for an extension of the training program in Environmental Biostatistics at the Harvard T. H.
Chan School of Public Health. The program prepares pre-doctoral and postdoctoral fellows for research in the
application of biostatistics, statistical genetics and genomics, and data science to the environmental health
sciences. The program will be administered through the Department of Biostatistics, with active participation
by faculty members from the Department of Environmental Health and the Department of Epidemiology, also
located at Harvard Chan. Trainees will receive high-quality instruction in basic biostatistical theory and
methods, such as probability, statistical inference, computing and data analysis. The program also provides
training in specialized topics of particular relevance for environmental applications, such as longitudinal and
spatial data analysis, Bayesian methods, machine and statistical learning, causal inference, statistical genetics,
environmental genomics and other high-dimensional data techniques. Training will also be provided through
substantive course work in environmental health, a regular seminar series called “Environmental Statistics”,
where faculty, students, and fellows present their own environmental health-related research, and annual
symposia. An important focus of training will be the opportunity to collaborate with faculty members from all
three departments on biostatistical research as it applies to environmental health. All trainees will participate in
Harvard's program on scientific integrity in the conduct of research, formal coursework on methods to ensure
reproducible science, formal, hands-on training in strategies for effective interdisciplinary collaboration and
scientific leadership, and practice in grant writing. The program develops an individual development plan for
each trainee, implements a formal mentoring program for junior faculty preceptors, and regularly assesses
current practices by polling current trainees and alumni. Program trainers place particular importance on the
recruitment of students from underrepresented minority groups, participating heavily in a well-established
summer program for undergraduates that consistently places graduates in the program. The focus on
interdisciplinary training at the Harvard T. H. Chan School of Public Health, as well as its talented and diverse
student body and faculty, makes it ideally suited for a training program in Environmental Biostatistics.

Public health relevance
The Training Program in Environmental Health Biostatistics at the Harvard T. H. Chan School of Public Health prepares pre-doctoral and postdoctoral fellows for research in the application of biostatistics, statistical genetics and genomics, and data science to the environmental health sciences. The Program combines first class training in biostatistical theory and methods, formal training in computer science and environmental health, practical experience in environmental health collaborations in interdisciplinary team science settings, and rigorous training in reproducible science. The Program provides trainees with skills necessary for scientific leadership in interdisciplinary settings, focusing on skills for project management, grant writing, and other skills needed for scientific leadership.